Quantitative Recovery of Biomolecular Structural Ensembles from Cryo-EM

Project Summary
Cryogenic-sample electron microscopy (cryo-EM) presents a unique opportunity to understand protein
conformational change. In cryo-EM experiments, a solution of biomolecules is snap-frozen, trapping them in
conformations close to the ones they adopt in solution. Modulo the effects of freezing on the conformational
ensemble, we should be able to quantitatively recover the probabilities of protein conformational states
from cryo-EM. In prior work, we developed a framework for addressing this challenge. For a hypothesized
conformational ensemble, we simulate a cryo-EM experiment and see how well the resulting images match
the experimental data. The better the match, the more likely the conformational ensemble is to be correct.
Preliminary results suggest that this approach can recover accurate conformational probabilities from cryo-
EM data, even in high noise regimes when it is impossible to accurately classify individual images. We plan
to build on these promising preliminary results by developing new algorithms that will aid us in recovering
conformational probabilities accurately and at scale. To scale our formalism to larger datasets and more
conformations, we first aim to accelerate the comparison of simulated and experimental cryo-EM images
using a combination of hierarchical clustering and heuristic search. By leveraging these twin strategies,
we can efficiently match experimental to simulated images, minimizing the computational power required
by our formalism. We also seek to improve the way we represent our conformational ensemble. Diffusion
models, a family of generative neural networks, have seen considerable practical use for protein design.
By training our diffusion model to match experimental data, we gain a flexible, fast, and accurate way
to encode the ensemble of protein conformations. Moreover, our work will open the door to foundation
models for protein conformational ensembles: generic models that can be used to predict conformational
changes for all proteins. In parallel with our algorithmic work, we will attempt to push the limits of
heterogeneity analysis for cryo-EM by attempting to recover the conformational ensemble of intrinsically
disordered regions (IDRs). Historically, this has been seen as an impossible task due to the prohibitive
difficulty of determining what IDR conformation a given cryo-EM image represents. But our formalism
doesn’t require solving this problem: it is enough to recover the statistical properties of the image set.
Consequently, we believe our method can succeed where traditional approaches have failed. Ultimately,
the proposed work will transform cryo-EM into a tool that can efficiently recover protein conformational
ensembles with quantitative probability estimates. This will shed new light into how proteins move to
accomplish their biological tasks, helping scientists understand protein function, facilitate the design of
new proteins, and discover new druggable mechanisms.

Public health relevance
Project Narrative Proteins are biomolecules that perform the vast majority of cellular tasks: they catalyze metabolic re- actions, transport molecules between parts of the cell, and read our DNA. Understanding how proteins accomplish these tasks requires knowing what specific shapes, or conformations, they adopt. To help un- derstand this interplay between structure and function, we will develop and refine new algorithms that can quantitatively recover the ensemble of possible conformations from single-protein images taken from cryogenic-sample electron microscopy (cryo-EM) experiments.